Administration

ADMINISTRATION: ABSTRACT
The goal of Administration is to operationalize the University of Florida Health Cancer Center (UFHCC) strategic
plan, allocating and managing the resources required for collaboration across the institution, with other Cancer
Centers, and with our community partners to enable novel, transdisciplinary cancer research impacting our
catchment area. To achieve this goal, UFHCC Administration provides administrative leadership, oversight, and
support for the research initiatives of the UFHCC members, promoting and coordinating the intra- and inter-
programmatic transdisciplinary activities of this matrix center within the University of Florida, and supporting a
culture of team-based success. UFHCC Administration provides operational leadership, organization, and
financial oversight in support of the activities of the director, senior leadership, research program leaders, shared
resources directors, and all UFHCC members. Administration supports 147 UFHCC members in 3 research
programs from 40 departments in 11 University of Florida colleges. UFHCC Administration leverages the
expertise of its experienced staff centrally located to function in an efficient and value-added manner in support
of the mission of the center. The areas of responsibility and functions of Administration include management of
1) strategic planning and evaluation activities; 2) fiscal oversight and allocation of institutional funds, including
philanthropy; 3) faculty recruitment and retention; 4) UFHCC membership process; 5) UFHCC shared resources;
6) UFHCC research programs, seminars, symposia, and scientific program retreats; 7) space allocation; 8) pre-
and post-award activities of complex grant mechanisms; and, 9) UFHCC pilot grant processes. Key
accomplishments of UFHCC Administration since 2016 include a) supporting the strategic recruitment of 58 new
members (45 external), that include 39 early-stage investigators, resulting in a >55% increase in cancer-relevant
peer-reviewed direct cost research funding from $21M in 2016 to $32.6M in 2021; b) developing and
implementing an integrated electronic data warehouse (EDW) for strategic planning and reporting purposes; c)
establishing the UFHCC Office of Community Outreach and Engagement and launching community engagement
efforts including Project CONTINUITY, linking community residents to cancer screening and care; d)
reconfiguring the Biostatistics and Quantitative Sciences Shared Resource as a UFHCC-managed shared
resource; and, e) engaging with other Florida-based cancer centers via the Florida Academic Cancer Center
Alliance in collaborative research projects, meetings, and co-sponsored retreats. Future plans include
implementing the new strategic plan, Momentum 2027, enhancing EDW reporting capabilities, managing CCSG
reporting and renewal, assisting the 2 developing shared resources to become fully operational within the next
3 years, facilitating and monitoring progress of the UFHCC Plan to Enhance Diversity, and measuring the impact
of the UFHCC on the cancer burden of the catchment area.